CHILD DEVELOPMENT TO AGE TEN AND PARENTAL SMOKING

This project aims to assess the relationship of both prenatal and postnatal parental smoking to the child's development and health at age ten. Longitudinal data have been collected for all children born in Great Britain from April 5 to 11, 1970, who were first surveyed at birth, and again at ages five and ten (n = approximately 12,500 at age ten). The data derived from this large and fully representative national population allow us to address key issues in a deeper and more comprehensive way than could any cross-sectional survey, no matter how detailed, and at a level of generalization only rarely possible. Finally, the special nature of this study is the richness of the data resources. We have demonstrated that differences in development between children of smoking and nonsmoking parents at age five depend in large part on the different social and behavioral characteristics of smokes and nonsmokers, although significant, but relatively small associations, do remain after controlling for social and other family differences. Without the extensive social and environmental assessment we have made of the families of the cohort children, such analyses would be incomplete, and indeed misleading. The longitudinal data will allow us to relate changing parental smoking to changing child health and development, as well as to control for changed social circumstances. Not only must social differences be controlled analytically: much of the effect of smoking in general, and of parental smoking on the child in particular, appears to be contingent on low social status, and we will explore such contingent effects. All developmental indices related in past research to parental smoking have been extensively assessed: somatic development, cognition and school achievement, motor coordination, hyperactivity and other behavioral abnormalities, as well as respiratory illness and symptomatology, now reported by both parent and child. We also will now add maternal alcohol use in pregnancy to the independent variable set, and the child's own smoking at ten, both as a dependent variable, considering it as a consequence of past and current social and behavioral circumstances, and as a determinant of current health and development.